Characterizing IL-22 driven chronic immune activation in HIV/TB co-pandemic

Project Summary
The Human Immunodeficiency Virus (HIV) and tuberculosis (TB) co-pandemic poses a major healthcare burden
in resource-limited countries. HIV co-infection predisposes the host to reactivation of latent tuberculosis infection
(LTBI) resulting in worsening of disease conditions and mortality. The most well characterized impact of HIV is
the CD4+ T cell depletion in lymphoid tissues and peripheral blood. However, studies using the nonhuman
primate (NHP) model of M. tuberculosis (Mtb)/SIV co-infection have revealed protective CD4+ T cell-independent
immune responses that suppress LTBI reactivation. Recent work shows that the mere depletion of CD4+ T cells
is insufficient to cause LTBI reactivation in SIV co-infected macaques. Instead, chronic immune activation
appears to be the key correlate for reactivation. Further, highly effective combinatorial antiretroviral therapy
(ART), while effective in reducing viral loads in the periphery and lungs of Mtb/SIV co-infected macaques, fails
to reduce the rate of reactivation of LTBI. Thus, understanding the driving forces behind chronic immune
activation in a relevant co-infected preclinical model underscores the discovery of key biomarkers and
development of intervention strategies.
We therefore aim to gain insight into the mechanism of mucosal damage, a paramount factor in chronic immune
activation, during SIV/TB co-infection. Towards this end, we will investigate the role of IL-22, a key cytokine in
protection from HIV and respiratory diseases including TB. We hypothesize that IL-22 protects the lung from
damage during LTBI and SIV co-infection abrogates this protection by IL-22 perturbation. We aim to identify the
mechanism by which IL-22 disarms the host immune response leading to SIV-driven immune activation and
ultimately, the reactivation of LTBI, in a macaque model of SIV/TB co-infection. In Aim 1 we will study the
functional role of IL-22 in Mtb/HIV co-infection. We will determine the levels of IL-22 production by CD4+ and
CD8+ T cells as well as non-T-cell populations, NKp44+ cells, and CD103+ dendritic cells in the blood, lymph
node and colorectum of co-infected macaques and in response to ART intervention (1a). We will also identify
the frequency of polyfunctional Th17 cells producing IFNγ, IL-17, IL-22, TNFα, production of antimicrobial
peptides; defensin-β, REG-3 proteins and S100A8/A9 proteins in the bronchoalveolar lavage fluid, colorectum,
lung tissue lysates of co-infected macaques and in response to ART intervention (1b). In Aim 2, we will study
the impact of SIV-induced IL-22 loss on LTBI reactivation. We will first determine whether the presence of IL-
22R expressing macrophages in non-necrotic granulomas of LTBI macaques correlates with protective control
of Mtb (2a). We will then perform transcriptional profiling on sorted cell subsets and mononuclear cells isolated
from blood, lymph nodes, lungs and colorectal mucosa before and after SIV infection to determine the impact of
IL-22 loss on immune activation and subsequent LTBI reactivation (2b). Understanding the mechanism of IL-22
perturbation in HIV/TB will lead to identification and development of antibody-based therapeutics or use of
recombinant IL-22 to prevent reactivation of LTBI in coinfected cohorts.

Public health relevance
Narrative Chronic immune activation appears to be the key correlate for reactivation of tuberculosis by HIV. We are therefore addressing the mechanism(s) by which SIV-mediated loss of protective IL-22 results in prolonged immune activation ultimately leading to LTBI reactivation, disease progression and mortality. Elucidating the key steps leading to worsening of the co-pandemic will enable identification of key target biomarkers for therapeutic interventions.